Novel Plasmin-independent Thrombolytic Agent for Pulmonary Embolism

Project Summary
Pulmonary embolism (PE) is the leading preventable cause of death among hospitalized patients, yet current
thrombolytic therapies are hindered by significant limitations, including high bleeding risks and incomplete clot
resolution. The high incidence and life-threatening nature of PE highlight the critical need for safer and more
effective thrombolytic solutions. Despite decades of research, the available thrombolytics remain exclusively
plasmin-based. These therapies activate plasminogen to plasmin, an enzyme that indiscriminately degrades
essential hemostatic proteins, such as fibrinogen, necessary for clot stability and wound healing. This lack of
specificity not only increases the risk of severe bleeding complications but also restricts the clinical applicability,
leaving a substantial unmet need for innovative alternatives to address PE effectively and safely.
SNJ Pharma, Inc. has developed a novel plasmin-independent thrombolytic enzyme, High-Temperature
Requirement A1 (HtrA1), as a promising alternative to current plasmin-based therapies. The recombinant form
of HtrA1 (rHtrA1) exhibits robust fibrinolytic activity, effectively dissolving intravascular clots while sparing
essential hemostatic proteins, such as fibrinogen. This unique mechanism avoids plasmin generation, enabling
rHtrA1 to selectively degrade pathological thrombi without increasing bleeding risk, a common limitation of
traditional thrombolytics. In mouse models of PE, rHtrA1 demonstrated exceptional efficacy, completely
dissolving clots and achieving a 100% survival rate. Building on this success, the proposed study will further
evaluate the therapeutic potential of rHtrA1 in a murine PE model, focusing on establishing a dose-response
relationship and determining the effective dose. Successful completion of this research will lay the groundwork
for a groundbreaking therapeutic approach, addressing critical unmet needs in the thrombolytic treatment of PE
while minimizing bleeding complications.

Public health relevance
Project Narrative Pulmonary embolism is the most common preventable cause of death in hospitalized patients. Current treatments, including anticoagulants and thrombolytics, have limitations such as bleeding risks and incomplete clot resolution. SNJ Pharma, Inc. has identified a novel protease that appears to exert strong thrombolytic activity on intravascular clots without serious bleeding risk. Testing this protein in a mouse model is proposed to determine dose response, leading to identification of therapeutic candidates for pulmonary embolism.